TOLERANCE INDUCTION

The second symposium on Tolerance Induction will bring together leading scientists in the field in an effort to catalyze scientific inquiry and accelerated dissemination of new information in this rapidly evolving approach to clinical transplantation. The format for the symposium will be four morning plenary sessions with 23 invited speakers, two evening sessions for 24 paper presentations and one evening session for posters. The mix of well established and young investigators in the setting of a small conference (150 attendees) has been designed to stimulate cross- fertilization of new ideas and the development of innovative approaches. Publication of the proceedings within three months will aid in early transfer of information to a larger audience. The ultimate goal is to accelerate the development of practical clinical protocols for tolerance induction in man.